Development and Function of Sleep Circuits - Extramural Research Programs in the Neurosciences and Neurological Disorders

We have little current understanding of the genetic and molecular mechanisms that link brain
development and the proper regulation of sleep throughout life. Understanding these mechanisms is a
longstanding challenge in sleep biology with great clinical relevance. Neurodevelopmental disorders including
autism are prevalent and closely associated with sleep disturbances, but the underlying genetic and
neuroanatomical mechanisms remain obscure. Our studies use the powerful Drosophila model system to
characterize a conserved genetic pathway whose activity is required during neuronal development for the
sleep regulation in adulthood. This pathway is composed of Insomniac (Inc), the Cullin-3 (Cul3) ubiquitin
ligase, and their targets. Reduced activity of this pathway in the developing brain severely curtails the duration
and consolidation of sleep in adulthood. Our findings suggest that this pathway has two distinct developmental
functions that influence the structure and function of the mushroom body, a sleep regulatory center in the fly
brain. In Aim 1 we will determine whether inc acts in neuroblasts to control the proliferation and number of
sleep-regulatory neurons. We will also validate Inc substrates, including a target that may link Inc to
asymmetric neuroblast division. In Aim 2, we will determine whether inc acts post-mitotically to regulate the
structure and anatomy of sleep-regulatory neurons. In Aim 3, we will determine how inc affects the function of
sleep-regulatory circuits. Because all of the genes under study are conserved and expressed in the
mammalian brain, our studies may provide insight into mechanisms underlying normal sleep, sleep
dysfunction, and various neurological disorders.

Public health relevance
Although we spend one third of our lives asleep, the molecular mechanisms that regulate sleep remain poorly understood. We will use the powerful and genetically accessible fruit fly to characterize several evolutionarily conserved genes that link brain development and the control of adult sleep-wake cycles. Because these genes are shared with humans, our studies may have broad implications for understanding normal sleep and for the diagnosis and treatment of sleep dysfunction.